7 Tesla Gradient Coil Upgrade for Human Ultra-High-Field MRI

? DESCRIPTION (provided by applicant): This shared instrumentation grant proposal seeks to upgrade the gradient coil of the 7T MRI scanner that is currently operational at the Center for Biomedical Imaging at New York University. The aforementioned scanner has been operational since 2006. This instrument has been pivotal for supporting novel imaging projects that are unpractical or not feasible at lower field strength. When the system was installed, it had the most recent gradient coil commercially available. The capabilities of this coil have since been surpassed by what is currently being shipped with newer units. Upgrading the system with the proposed gradient coil will bring it on par with the capabilities of the systems being in productio at this time. This will not only extend the useful life of the current system but, in addition, mak state-of-the-art technology available to the advanced imaging projects being carried out New York University.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal will provide funds for improving the imaging gradient capabilities of the 7T whole-body MRI human scanner at New York University. This scanner is an essential tool for the study of Central Nervous System's diseases such as Alzheimer's disease and Bipolar Disorder, and the increased sensitivity of the scanner has allowed us to measure changes in brain neurochemistry and anatomy that provide unique insights into the pathogenesis and evolution of these diseases. In addition, the unique contrast mechanisms available at 7T have led to novel diagnostic paradigms that for important pathologies for which current MRI technology cannot provide a definitive diagnosis.